Cannabinoid inhibition of CNS inflammasome activation via modulation of the gut-brain axis

ABSTRACT
The primary objective of this proposal is to investigate Cocaine/HIV/SIV induced changes in inflammasome
activation and their epigenetic regulation in the intestine and brain and its modulation by long-term, low-dose
cannabinoids and combination antiretroviral therapy. The NLRP3 (NOD-like receptor family, pyrin domain
containing) inflammasome is a multiprotein complex that elicits an innate immune response to infection and cell
stress through activation of caspase-1 and processing of pro-interleukin-1β (pro-IL-1β) and pro-IL-18 to the
bioactive IL-1β and IL18, respectively. Cocaine induces expression of inflammasomes and their associated
genes in chronic HIV/SIV infection leading to persistent CNS and gastrointestinal tract (GIT) inflammation, which
contributes to microbial translocation, immune activation, and HIV disease progression. Nevertheless, the
epigenetic regulation of HIV/SIV and cocaine-induced inflammasome activation and its modulation remains
unknown and needs to the investigated to better understand disease pathogenesis. Therefore, here we propose
that supplementing 9-THC along with cART may reduce cocaine-induced inflammasome activation, dysbiosis,
restore immune function, and slow HIV/SIV disease progression by modulating DNA methylation and gene
expression. Our preliminary data showed marked to significant upregulation of caspase-1, gasdermin and
NLRP6 inflammasome gene expression in basal ganglia (BG) and colonic epithelium (CE), respectively of
chronically SIV-infected rhesus macaques. Interestingly, increased NLRP6 gene expression in CE was
accompanied by extensive CpG promoter hypomethylation of up to 12 CpG sites. More importantly, long-term
9-THC administration significantly reduced CASP1 and IFN stimulated gene expression in BG and NLRP6 DNA
hypomethylation in CE. Therefore, we will test the central hypothesis that a) aberrant DNA hypomethylation of
inflammasomes and their associated genes in cocaine induced during chronic HIV/SIV infection results in their
elevated expression leading to persistent CNS and GIT inflammation, which in turn contributes to microbial
translocation, immune activation (microglial and T cells), and HIV disease progression; b) combining cART with
low-dose of THC as a therapeutic may reduce cocaine-induced inflammasome activation, gut dysbiosis, and
restore immune function. In order to test this hypothesis, we have proposed three specific aims. We will first
investigate epigenetic mechanisms underlying cannabinoid-mediated reduction of cocaine-induced
inflammasome activation in blood monocytes, brain, and CE during chronic SIV infection (aim 1). Next, we will
determine the ability of THC administered in conjunction with cART to reverse cocaine-induced dysregulation of
the microbiota-gut-brain axis (aim 2) and finally identify potential molecular mechanisms associated with THC
counteraction of cocaine-induced DNA hypomethylation and inflammasome activation in in vitro cultured
microglia, and CE cells (aim 3). The new findings from these studies will have important therapeutic implications
for immune modulation in not only HIV but also other chronic intestinal inflammatory/neurodegenerative disease.

Public health relevance
NARRATIVE The proposed studies will provide a better understanding of the molecular basis of cocaine induced GI epithelial and neurological dysfunction and its modulation by low-dose cannabinoids.in HIV/SIV infection. In addition, the proposed studies may lead to development of targeted anti-inflammatory therapies using low-dose cannabinoids in conjunction with cART to treat not only HIV/SIV but also numerous other chronic intestinal and neuroinflammatory diseases.